The glucocorticoid receptor as a top-down neuromolecular mechanism of inhibitory control

Abstract
Environmental stimuli, or cues, can elicit maladaptive behavior. This is particularly observed in those with
psychiatric disorders like substance use disorder (SUD), where a cue that is associated with prior drug use
(e.g. paraphernalia), can result in relapse regardless of the individual’s desire to remain abstinent. Such cue-
motivated behaviors are a result of behavioral disinhibition, or a lack of inhibitory control. Deficits in inhibitory
control are broadly referred to as “impulsivity”, a term further defined by 1) heightenedكresponsiveness to
reward-associated cues (i.e., reward sensitivity) and 2) impulsive actions conducted without regard to risk or
consequences (i.e., rash impulsivity). Studies in humans and rodents show that individuals with heighted
reward sensitivity also exhibit increased rash impulsivity. Both facets of impulsivity contribute to maladaptive
behaviors, yet the neural underpinnings of these processes remain elusive. An overarching goal of this
proposal is to determine whether both facets of impulsivity share the same neural mechanism. Specifically, this
research focuses on a "top-down" inhibitory control pathway: the prelimbic cortex (PrL) to the nucleus
accumbens core (NAcC). Glutamatergic projections from the PrL to the NAcC have been shown to modulate
reward-seeking behavior and regulate NAcC dopamine (DA) activity. DA signaling in the NAcC also underlies
impulsive action (rash impulsivity) and the attribution of incentive motivational value, or salience, to a reward
cue (reward sensitivity). However, the mechanism by which these interactions occur within this pathway is
unclear. The proposed research will investigate the glucocorticoid receptor (GR) as a neuromolecular
mechanism within the PrL-NAcC pathway that regulates reward sensitivity and rash impulsivity via its effects
on NAcC DA signaling. While the GR is known as a primary regulator of stress responsivity, it also regulates
NAcC DA and plays a role in reward-related behaviors, including reward sensitivity. In addition, GR has been
implicated in psychiatric conditions characterized by behavioral disinhibition. To examine the role of GR in
inhibitory control processes, transgenic rats with conditional GR knockdown alleles will be employed to
selectively knock down GR in PrL-NAcC projection neurons. Aim 1 will assess the effects of this manipulation
on reward sensitivity using a Pavlovian conditioned approach paradigm that captures variability in the
attribution of incentive salience to a reward cue. Aim 2 will assess the effects of GR knockdown on rash
impulsivity using a Go/No-Go paradigm to measure the inability to withhold behavior in response to a cue. For
both Aims, fast-scan cyclic voltammetry (FSCV) will be used to measure DA signaling within the NAcC in
response to the reward-associated cue (Aim 1) and the “Go-“ and “No-go” cues (Aim 2). This research has the
potential to uncover a neuromolecular mechanism of inhibitory control and, in turn, lead to better treatments for
psychiatric disorders characterized by dysfunctional impulsivity.

Public health relevance
Project Narrative: The proposed research aims to uncover the neural mechanisms that promote impulsivity, a multifaceted construct defined broadly by deficits in inhibitory control. Dysfunctional impulsivity is observed across psychiatric disorders, including impulse control disorders (ICDs), substance use disorders (SUDs), eating disorders, and attention-deficit hyperactivity disorder (ADHD). Thus, a better understanding of neural mechanisms underlying impulsivity could yield novel treatments for psychiatric disorders characterized by deficits in inhibitory control.